A Program for Innovative PET Radioligand Development and Application - A Translational Toolbox for Treatments for Mental Health

Project Summary/Abstract
Advances in molecular neuroscience, genetics, and basic behavioral science have vastly expanded our
knowledge and understanding on the etiology and pathophysiology of mental illness, and identified new
molecular targets for therapeutic development. PET imaging has similarly expanded dramatically and now
provides critical translational tools for molecular imaging and therapeutic development in mental disorders. PET
imaging with target-specific radioligands has played a critical role in the elucidation of molecular targets, such
as receptors and transporters for the dopamine, serotonin, opioid, GABA, glutamate, endocannabinoid, and
acetylcholine systems, in the pathophysiology of depression, schizophrenia, and other mental disorders. The
availability of suitable radioligands is key to exploring the full potential of PET imaging in mental health research.
The goal of this renewal application is to advance an innovative program in the development, validation, and
application of novel PET radioligands to probe high priority molecular targets implicated in mental health
disorders. This program builds on the Yale PET Center's outstanding capability in radioligand development and
clinical evaluation. We use a tiered development strategy: Tier 1 - Chemistry development and in vitro testing;
Tier 2 - In vivo assessment in non-human primates; Tier 3 – First-in-human proof of concept/validation studies;
and Tier 4 - Application to investigate mechanisms of mental illnesses. Radioligands enter the development
scheme at any tier when there is sufficient rationale that advancing the radioligand can inform disease
mechanisms of relevant mental disorders. The program's External Scientific Panel and Steering Committee
(NIMH program leaders, industry and academic subject-matter experts, and Yale scientists) hold annual
meetings to nominate new targets and review ongoing data to optimize the radioligand pipeline. Radioligands
developed and data generated under the program are disseminated via a dedicated website, conference
presentations and publications, and shared with the PET imaging and mental health research community.
This program aligns tightly with NIMH priorities by involvement of NIMH program officers in the decision-
making process, and engages the entire PET tracer development and imaging community in the common
endeavor to validate novel radioligands for molecular targets important in mental health research. The initial
funding cycle resulted in the validation of a novel agonist tracer for the dopamine D1 receptor, the first-in-human
testing of radiotracers for histone deacetylase 6 (HDAC6) and monoacylglycerol lipase (MAGL), and most
significantly, the development of first-in-class radiotracers for the GABA transporter-1 (GAT-1), and best-in-class
radiotracer for the GluN2B subunit of the NMDA receptor complex, which we propose to translate to first-in-
human evaluation in this renewal application. Success in the next cycle will see validation of first-in-class and
best-in-class radiotracers for imaging and quantification of GAT-1, GluN2B, and AMPA receptors in humans,
and development of novel radiotracers for new targets to advance mental health research through PET imaging.

Public health relevance
Project Narrative In this renewal application we propose to advance a unique, innovative program on the discovery, development, validation, and application of novel radioligands for positron emission tomography imaging to probe high priority molecular targets involved in mental health disorders. Success of this program will contribute to the elucidation of the etiology and pathophysiology of mental diseases, and facilitate the development of effective treatments.